Implicit serial learning

Project Summary
Reinforcement learning (RL) is a powerful framework for understanding outcome-driven behavior and its neural
basis. A key issue for RL is how to incorporate an ability to make inferences that allow appropriate responding
to novel conditions not encountered during training. Inference relies on the detection of latent relationships that
predict rewards but are not signaled by explicit cues. In the previous funding period, we developed behavioral
and computational approaches to rigorously address this problem, and made single-cell neurophysiological
observations that began to reveal how the brain represents latent structures. Here, we re-conceptualize this
problem as one of using a cognitive map to represent latent order and support inference. We propose to test
this idea with a newly developed behavioral approach, which allows unprecedented insight into the role of
cortico-striatal neural circuits and ascending neuromodulatory systems in model-based RL. These
investigations will focus on brain regions that neurophysiology, neuroimaging, and lesion studies suggest have
important roles in implicit serial learning, specifically dorsolateral (dlPFC) and ventromedial prefrontal cortex
(vmPFC), and dorsal striatum. Three aims will 1. Test NHPs ability to make model-based inferences in the
presence of countervailing reward incentives, 2. Identify neural circuitry of serial learning in the dlPFC, vmPFC,
and caudate nucleus, and 3. Test if changes in Ach and DA concentrations are correlated with serial learning,
particularly during transfer. Inferential reasoning is impaired in many psychiatric illnesses including
schizophrenia and bipolar disorder. This impairment may underlie thought disorders such as delusions and
paranoia.

Public health relevance
Project Narrative The goal of this project is to investigate how non-human primates learn and represent information about serial order using inferential reasoning. We propose that serial order is learned using cognitive maps that support inference and thus allow organisms to adapt to novel circumstances. Health Relatedness: These experiments are relevant to Schizophrenia, Autism, Alzheimer’s disease, and other conditions whose patient populations have cognitive deficits, specifically those related to reasoning.